Dissecting How SYNJ2 Facilitates mRNA Targeting and Translation at Neuronal Mitochondria

ABSTRACT
Neurons consume a disproportionate amount of energy compared to other cell types. This heightened OXPHOS
activity helps support membrane polarization and synaptic transmission. Consequently, a single neuron must
maintain a mitochondrial network spread throughout the neuropil with spatiotemporal precision. One molecular
mechanism to maintain local mitochondrial health is through trafficking of PINK1 mRNA. PINK1, a Ser/Thr kinase
mutated in familial forms of Parkinson’s disease, accumulates on depolarized mitochondria to initiate mitophagy.
The Schwarz lab has recently demonstrated that PINK1 mRNA is co-trafficked with neuronal mitochondria,
including in axons. Synaptojanin2 (SYNJ2) was identified as the key RNA-binding protein (RBP) that anchors
PINK1 mRNA to the outer mitochondrial membrane in neurons. Our lab has subsequently created model systems
to dissect phenotypes solely dependent on the RNA-binding function of SYNJ2. Specifically, three point
mutations in the RNA recognition motif of SYNJ2, which abolishes SYNJ2-mRNA interaction, have been
introduced in a mouse model and human-derived iPSC neurons. My proposed fellowship research will harness
these model systems to investigate the biology behind local mRNA trafficking and translation. In Specific Aim 1,
I will determine cis-regulatory elements that target mRNA to mitochondria in a SYNJ2-dependent manner. I will
use live mRNA imaging, RNA structure prediction, and targeted deletion of candidate sequences to achieve this.
Then, in Specific Aim 2, I will determine if SYNJ2 and/or the outer mitochondrial proteome is required for local
translation of PINK1 mRNA. To accomplish this, I will artificially tether PINK1 transcripts to mitochondria using
viral stem loops, overriding the need for SYNJ2 trafficking. Additionally, I will mistarget PINK1 transcripts to
lysosomes. Broadly, my proposed research will elucidate molecular mechanisms underlying decentralized
organelle biology in neurons, with important implications for neurodegenerative disease.

Public health relevance
PROJECT NARRATIVE Neurons depend on the local transport of mRNA to maintain healthy axons and dendrites. Our laboratory has demonstrated that mRNA encoding PINK1, a gene associated with Parkinson’s disease, is locally trafficked with neuronal mitochondria through a protein anchor called synaptojanin2. My project aims to determine precisely how mRNAs can be targeted to mitochondria in this fashion, and how important this particular targeting mechanism is for PINK1 function.